Pacemakers of Cholinergic Wave Activity in the Developing Retina

PROJECT SUMMARY
Before the emergence of vision, spontaneous retinal wave activity is essential for retinal layer-specific
angiogenesis and dendritic maturation of retinal ganglion cells, as well as for the refinement of eye-specific
segregations and retinotopic maps. A subpopulation of retinal amacrine interneurons, called starburst amacrine
cells, initiate and propagate retinal waves through recurrent cholinergic connections called cholinergic retinal
waves. However, the mechanisms underlying cholinergic wave initiation and propagation are poorly defined.
Currently, the most urgent priority is to define how cholinergic waves are initiated to create a framework for
understanding their downstream propagation. This project's objective is to identify a subset of starburst amacrine
cells that serve as cholinergic wave pacemakers and the mechanisms by which pacemaker starburst amacrine
cells generate these waves. Preliminary data from the PI's laboratory demonstrate that it is feasible to identify
pacemaker starburst amacrine cells and the sufficiency of a single pacemaker starburst amacrine cell to initiate
a wave. Wave generation requires activation of voltage-dependent calcium channels. These novel findings lead
to the central hypothesis: single pacemaker starburst amacrine cells initiate waves by a calcium-dependent
mechanism. To test this hypothesis, the team will determine the distribution and properties of cholinergic wave
pacemakers (Aim 1), and identify the calcium-dependent mechanisms of cholinergic wave generation (Aim 2).
The work on understanding the identity and features of pacemaker starburst amacrine cells and the ionic
mechanisms of cholinergic retinal wave generation will advance knowledge of how retinal waves mediate
vascular and neuronal development of the retina as well as eye-specific segregation and retinotopic map
refinement in the visual centers of the brain.

Public health relevance
PROJECT NARRATIVE This project is relevant to public health because spontaneous neural activity occurs in the visual brain centers of the human fetus in order to refine neural circuit development. The early termination of spontaneous neural activity in nearly 40,000 infants born prematurely each year in the United States may cause neurodevelopmental disorders and visual impairment. Results from this study will advance our understanding of the cellular and neural circuit mechanisms of neurological disorders and vision problems.